Montessori Approaches in Person-Centered Care (MAP-VA): An Effectiveness-Implementation Trial in Community Living Centers

Background: VA Community Living Center (CLC) staff struggle to address behavioral and neuropsychiatric
symptoms of Veterans with dementia and serious mental illness (SMI) such as schizophrenia. These behaviors
of distress (agitation, aggression, and mood disturbance) are not just associated with staff stress and burnout;
they also hasten residents’ functional decline, decrease quality of life, and increase mortality. Staff training in
non-pharmacological interventions can be effective. Yet systems barriers, task-based traditional biomedical
care models, and time constraints often result in staff employing “quicker,” less effective strategies.
Montessori Approaches to Person-Centered Care for VA (MAP-VA)— a staff training, intervention, and
delivery toolkit— developed in collaboration with VA operational partners, Veterans, and frontline CLC staff is
positioned to respond to this challenge. Our pilot data show probable impacts on CLC quality indicators at the
individual and unit level (e.g., psychotropic medications, depressive symptoms, weight loss, falls, pain).
Significance / Impact: Intense media scrutiny focused on care quality in VA CLCs has created an urgent
problem for VA over the past year. To restore perceived trust, safety, and quality— as described in VHA’s
Modernization Plan— frontline staff need to be empowered to lead quality improvement efforts like the ones
taught through MAP-VA.
Innovation: MAP-VA is distinct from existing interventions in its: 1) application to Veterans with a range of
diagnoses and cognitive abilities; 2) emphasis on pairing practical skill-building for staff with overcoming
system-level barriers that inhibit person-centered care; and 3) engagement of all staff rather than a reliance on
provider-level champions. Yet, MAP-VA is a complex intervention that requires participation of multiple
stakeholder groups, making implementation facilitation necessary. To date, no studies have evaluated MAP
implementation success in operational settings (community or VA) and sustainability is rarely examined.
Specific Aims: A hybrid (Type 3) implementation-effectiveness study is necessary to evaluate MAP-VA for
Veterans and staff in CLCs. Study Aims include: 1) evaluate implementation facilitation and identify barriers to
MAP-VA adoption and fidelity; 2) determine effectiveness of MAP-VA implementation on resident behavioral,
emotional, and physical health outcomes; 3) determine effectiveness of MAP-VA implementation on person-
centered care practices and organizational culture; and 4) examine the extent to which MAP-VA is sustained
after external facilitation support has ended.
Methodology: A stepped-wedge cluster randomized controlled trial will be used to evaluate within- and
between-cluster implementation success and treatment effects over 18 months. Eight CLCs (24 CLC
neighborhoods) will be randomized to a sequential crossover to the intervention with six months of facilitation.
Analyses will account for time trends and correlations within cluster. Normalization process theory and the RE-
AIM evaluation framework will guide the implementation evaluation and integration of qualitative and
quantitative data. Data sources include primary data collection (e.g., resident interviews, staff interviews,
surveys, researcher observation) and existing VA administrative data (e.g., Minimum Data Set 3.0, pharmacy,
disruptive behavior reporting system, annual employee survey).
Implementation / Next Steps: Our partners in the VA Offices of Geriatrics and Extended Care, Nursing
Services, Mental Health and Suicide Prevention, and Recreation Therapy are enthusiastic about using MAP-
VA to improve Veteran-centered care, care quality, and staff engagement within and beyond the CLCs.
Outcomes from this work will be applicable to supporting staff and improving quality for complex aging
Veterans across the continuum of care (e.g., Home Based Primary Care).

Public health relevance
Improving person-centered care, quality of life, and empowerment of residents and frontline care providers are urgent priorities across national agencies. Montessori Approaches to Person- Centered Care for VA Community Living Centers (MAP-VA) is an innovative intervention that offers practical strategies for progress in ways that engage and motivate frontline staff. Several innovations distinguish it from existing programs: (1) a unique emphasis on Veteran-to-Veteran engagement; (2) teaching staff to facilitate increased meaningful roles for residents; (3) specific tools for assessing resident strengths across varying abilities; (4) fostering environments that support independence; and (5) strategies to address system-level barriers that may stand in the way of providing person-centered care. Evaluation and implementation of MAP-VA has the potential to improve critical clinical outcomes for some of VHA’s most vulnerable Veterans.